Washington University Rheumatic Diseases Research Resource-based Center

The WU-RDRRC seeks to advance the health of patients with rheumatic diseases by supporting enabling technology and promoting the members’ basic, clinical, and translational research interests that are organized around three major themes: 1) elucidating basic mechanisms of inflammation and autoimmunity; 2) accelerating clinical/translational research to inform precision medicine; and 3) advancing genome engineering and regenerative medicine to develop new treatment approaches for rheumatic diseases.
We posit that translational research endeavors in rheumatic diseases require a team approach cultivated in a vibrant environment and supported by cross-disciplinary groups of experts and cutting-edge technologies. Over the past four years, this operational philosophy and the infrastructure supported by the WU-RDRRC perfectly positioned our investigators to increase the efficiency and impact of their research, allowed them to quickly address emergent issues that arose during the COVID-19 pandemic, and helped a number of young investigators obtain extramural funding and successfully transition to research independence. The WU-RDRRC propose to continue promoting rheumatic disease research by: 1) providing the infrastructure, education, and training needed to assist investigators with the experimental and scientific design of their projects; 2) organizing and supporting Core laboratories that will adopt and apply innovative technologies and expertise that would otherwise be unavailable to investigators in a cost-effective manner; 3) promoting interest in rheumatic diseases research by engaging multidisciplinary teams and bringing together research disciplines and clinical divisions to address roadblocks in translational science; 4) fostering the next generation of junior investigators who are interested in the study of rheumatic disease-related areas.
To accomplish our goals we propose four cores: 1) a Biobank and Phenotyping Core to collect high-quality biospecimens for downstream molecular analysis; 2) a Genome Engineering Core to generate bioengineered cell-based therapies, knockin/knockout mice for testing in preclinical disease models; 3) a Cellular Imaging Core that offers novel microscopy technologies for building models of health and disease; and 4) an Administrative Core that promotes collaborative and synergistic interactions among rheumatic disease researchers and the mentoring of junior and new investigators interested in rheumatic disease research.*

Public health relevance
OVERALL PROJECT NARRATIVE State-of-the-art technologies afforded by the WU-RDRRC will advance our understanding of the pathogenesis of rheumatic diseases through high impact basic and clinical/translational research endeavors conducted by cross-disciplinary teams of experts. Findings will potentially translate to improvements in treatment options for patients suffering from various rheumatic diseases.